Flow Cytometry

The TCI Flow Cytometry Shared Resource (FCSR) provides access to modern technologies, services, and expertise in flow cytometry to enhance scientific discovery and collaboration within the TCI community. The FCSR proactively monitors and introduces new flow cytometry equipment, methods, and data analyses approaches to promote impactful studies and align with the cancer center’s expanding needs. The FCSR maintains cancer-focused personnel and contributes to the TCI’s research mission by providing consultation, priority access with TCI dedicated equipment, education, and cost-effectiveness with center pricing and subsidies. The Specific Aims of this Shared Resource are to: (1) Provide access to state-of-the-art technologies, services, and expertise in flow cytometry-based investigations; (2) Monitor and integrate novel techniques, technologies, and equipment to enhance flow cytometric service and impact.